Real-Time Cell Analyzer Equipped with Impedance and Imaging Detectors

PROPOSAL SUMMARY/ABSTRACT
Real-Time Cell Analysis (RTCA) is a modern technique that enables scientists to detect both optical
(imaging) and electronic (impedance) signals based on events taking place inside mammalian cells.
Whereas commonly used endpoint techniques, including flow cytometry and cytotoxicity tetrazolium salt
assays, only collect data for a specific time point, RTCA collects data across various time points. With the
wide range of research applications of this technique, scientists across various fields can now figure out
answers to many of their research questions that conventional endpoint assays cannot provide. Thus, RTCA
can be seen as a revolutionary tool and a game-changer in biomedical research that is bound to have a high
impact vis-à-vis improving public health.
With this proposal, we seek to procure an RTCA system that will enable us to accomplish some of our short-
term and long-term objectives. Our short-term objective upon procuring an RTCA system is to (i) incorporate
the instrument into the learning objectives of two laboratory courses, (ii) develop a novel assay to study the
activity of a subset of bacterial and plant toxins, (iii) investigate and optimize the use of gold nanoparticles
as delivery systems as an approach to kill cancer cells, and (iv) investigate macrophages as a key target in
glioblastoma multiform cancer. Our long-term objective, on the other hand, is to attract researchers from
various fields within the School of Integrative Science and Technology at Kean University to become active
users on the instrument. Broad access on the instrument will be made available to our researchers to
conduct experiments related to their projects and/or to incorporate the instrument into the learning objectives
of their laboratory courses. Overall, we hope to have access to many modern instruments that will stimulate
the creativity and innovative spirit of our faculty and students to pursue their research questions in a manner
hitherto unseen before that may eventually have a high impact on public health.
Kean is a Resource-Limited Institution (RLI) serving a diverse population of students, and it is currently not
equipped with many modern instruments such as RTCA systems. The lack of access to modern scientific
equipments is one of the major barriers that RLI researchers face, which make finding answers to their
questions far more challenging. As a result, we are seeking to procure an RTCA system that will enable our
researchers to pursue their scientific quest, explore their research questions where they currently are unable
to, and enhance the learning experience that we provide Kean students.

Public health relevance
PROPOSAL NARRATIVE Real-Time Cell Analyzer (RTCA) systems provide multi-parameter temporal data about the health status of cells and is widely applicable in various biomedical research fields, including cancer and microbiology. We aim to incorporate RTCA into the learning objectives of two lab courses at Kean University as well as using this modern technique in various research projects. Thus, the RTCA system we are requesting in this proposal will provide students with an authentic research-based learning experience, and it will enhance the Kean’s research capacity.